Ultrasensitive detection of circulating DNA methylation for head and neck cancer prognosis

PROJECT SUMMARY/ ABSTRACT
Head and neck squamous cell carcinoma (HNSCC) is one of the most prevalent aggressive cancers
worldwide. Despite advances in diagnostics and treatments, the 5-year survival of HNSCC remains low
(~50%). Patients with HPV-negative tumors exhibited an even worse prognosis. There is a pressing and
unmet need to identify reliable molecular biomarkers for prognostic prediction in HNSCC, crucial for
personalized patient care. This enables the selection of more aggressive or novel treatments like
immunotherapy for high-risk patients, while also guiding treatment deintensification for those at low risk. DNA
methylation (DNAme) is a key player in all major cancer hallmarks, encompassing a range of processes from
tumorigenesis and cancer progression to its pivotal role in shaping the tumor-immune microenvironment and
influencing drug/treatment resistance. DNAme is also known to be responsive to both genetic variations and
environmental exposures, both of which are driving factors underlying the etiology and pathogenesis of
HNSCC. Building upon extensive preliminary data, we hypothesize that the incorporation of non-invasive and
ultrasensitive detection of circulating DNA methylation, including analysis of circulating cell-free DNA and
immune cells from peripheral blood, will markedly enhance the precision of prognostic predictions in patients
with HNSCC. In this R01 project, we propose to establish a dedicated clinical cohort of HNSCC named
PHENEX, along with novel analytical methodologies (Aim 1) to validate, discover and optimize noninvasive
liquid biopsy tests for HNSCC based on cell-free DNA methylome of plasma samples (circulating tumor
panel); (Aim 2) to uncover novel DNAme biomarkers in the matched peripheral immune cells to further
improve the liquid biopsy test for the prognostic biomarker discovery (circulating immune panel); and finally
(Aim 3) to investigate the potential of integrating cancer-specific and immune-specific biomarkers for
immunotherapy outcome prediction (PHENEX-IO). We will utilize an ultrasensitive technology developed by
our team, known as cfMBD-seq, for ultra-low-input DNA methylome analysis of HNSCC plasma samples. As
an integral part of our biomarker discovery process, the matched tumor tissues will also be profiled for
DNAme, providing a holistic understanding of the epigenetic landscape in HNSCC. The PHENEX cohort will
leverage both existing tissue samples collected from Moffitt Total Cancer Care (TCC) and established
biospecimen collection workflows for prospective sample collection, aiming to create an effective and
sustainable resource. This project will be undertaken by a team of investigators who have proven track record
and extensive experience in head and neck oncology and epigenomic biomarker discovery. Collectively, our
results are set to deliver an immediate translational impact by informing more precise therapeutic strategies
and clinical management of HNSCC, ultimately improving the overall outcome for patients battling this dismal
disease.

Public health relevance
NARRATIVE Despite improved treatment options, survival in patients with human papillomavirus-negative head and neck cancer remains poor and there are critical barriers in the personalized management and therapy of this challenging disease. Leveraging cutting-edge sequencing and novel analytical technologies developed by our team, we propose the largest prospective cohort study investigating multimodal blood-based DNA methylation makers for predicting individualized patient outcome. Findings will also lead to promising novel mechanisms and signatures essential for the development of targeted therapies in the future.